Neural Dynamics of Local Sleep Spindles and Their Role in Memory

Project Summary
During sleep, our brains remain active and exhibit a range of characteristic electrical signals not observed
during awake periods. These characteristic signals are assumed to be fundamental events in the sleeping
brain’s organization of information into our memories. The research described in this proposal will utilize
intracranial depth electrode data to further our understanding of memory consolidation in humans. Despite the
fundamental role sleep and memory play in our lives, little is definitively known about how memories are
formed and maintained. The availability of intracranial data presents a rare opportunity for fresh insight. The
research described in this proposal will determine the role local spindles play in memory consolidation.
Spindles are transient bursts of 11-16 Hz oscillations in the electroencephalogram, and their activity could
serve as a unique biomarker for mental health conditions and memory-related pathology and performance.
Spindles were once considered relatively uniform electrical events, globally distributed throughout the
neocortex. This understanding is complicated by recent findings of local spindles restricted to specific brain
regions. The role of local spindles in memory consolidation remains a mystery. Aim 1 will determine if local
spindle activity (like global spindle activity) is sensitive to the acquisition of new information related to a
procedural memory task. Task-related sounds played during sleep are known to reactivate the associated
memories and lead to improved recall of those memories after awakening. The replay of select auditory cues
during sleep, which is known to bias memory formation, will allow us to hone in on and examine the neural
dynamics associated with those particular moments in time. We will examine how the local spindle neural
dynamics that immediately follow cue presentation relate to improvement on the task. The use of intracranial
data will allow us not only to detect local spindles, but also to relate them to activity in deep brain structures like
the hippocampus, which is thought to play a critical role in sleep-mediated memory consolidation. Aim 2 will
employ the same procedure as in Aim 1, but using a declarative memory task in which subjects are asked to
recall the locations of various objects presented on a computer screen. Success in our aims will provide a
detailed understanding of how local spindle dynamics contribute to both declarative and procedural memory
consolidation and inform the broader effort to understand how oscillatory activity during sleep consolidates
memories. This work will also support the identification of effective sleep interventions for memory
improvement in health and disease.

Public health relevance
Project Narrative During sleep, our brains remain active and exhibit a range of characteristic electrical signals not observed during awake periods; these signals are believed to be fundamental to the organization of information into memories. The research described in this proposal will utilize intracranial depth electrode data to further our understanding of memory consolidation in humans during sleep. The knowledge gained from this work will not only advance our understanding of the mechanisms by which memories are formed in the normal working brain, but also help us understand how these mechanisms fail in the brains of those suffering from health disorders associated with cognitive and memory impairment.